Pilot--Effect of fatty acid supplementation &exercise on lipoprotein metabolism

DESCRIPTION: This project will determine the effect of medium and long-chain triglycerides and omega-3 fatty acids and exercise on lipoprotein metabolism.